Exploring polyamine toxicity and resistance in epidemic bacterial skin pathogens

Abstract.
Methicillin Resistant Staphylococcus aureus (MRSA) is an important human pathogen that exerts a tremendous
negative impact on human health. S. aureus stands out among other species of Coagulase-Negative
Staphylococci (CoNS) in that S. aureus specifically has evolved high pathogenic potential. Streptococcus
pyogenes (Group A Streptococcus or GAS) is also a dangerous human pathogen, and both species primarily
inhabit human skin. Polyamines or positively charged aliphatic molecules produced by almost all living things.
Curiously, both MRSA and GAS lack polyamines and certain ones are highly toxic to both pathogens. The high
level of polyamines in human skin must exert a tremendous selection on these pathogens because epidemic
clones of both have evolved resistance to polyamines. This proposal seeks to understand how polyamines enter
the cell, how they kill these bacteria and how these epidemic clones evolved resistance. We will also explore
developing novel synthetic polyamines that are capable of killing even resistant clones. We will validate that their
mechanism of action is the same as natural polyamines. This might lead to the development of novel effective
topical therapeutics against two important human pathogens.

Public health relevance
Narrative Methicillin-Resistant Staphylococcus aureus (MRSA) and Streptococcus pyogenes (Group A Streptococcus or GAS) are important human skin pathogens and both species are highly sensitive to polyamines, natural compounds found abundantly in mammalian skin. However, epidemic clones of both pathogens have evolved resistance to polyamines and in the case of MRSA, this results in a demonstrable fitness benefit. This proposal seeks to explore the mechanism of toxicity of polyamines towards MRSA and GAS and determine whether it can be exploited for novel topical treatments.